Sleep, Pain, Active Social Life, and Inflammation (SPAI)

Abstract
Chronic pain is a prognostic marker of illness and imposes a substantial burden on the healthcare system,
affecting approximately 20-30% of US adults. Sleep problems commonly co-occur with chronic pain, yet little is
known of how sleep impacts chronic pain. Social engagement and inflammation have relationships with both
sleep and chronic pain, but no study has examined these behavioral and biological mechanisms underlying the
impact of sleep on chronic pain. This R01 initiates a multi-cohort study to examine the extent to which the impact
of sleep on chronic pain is mediated by social lifestyles and inflammation. In this study, we take a sleep health
perspective to capture multiple sleep characteristics critical to chronic pain (regularity, satisfaction, alertness,
timing, efficiency, and duration). Based on multiple sleep variables captured by self-report, actigraphy, and/or
polysomnography, we will identify “sleep health profiles” (the composite number of sleep problems or latent
groups with similar sleep characteristics across multiple dimensions) and link them to chronic pain outcomes.
Our sleep profile approach has advantages because it can consider multiple sleep problems that may co-occur
within individuals, and may differentially impact pain outcomes. Leveraging three NIH-funded projects (Midlife
in the United States Study-MIDUS, Outcomes of Sleep Disorders in Older Men-MrOS, and Multicenter
Osteoarthritis Study-MOST), we examine multiple common chronic pain conditions prevalent in adult populations
(any chronic pain, back pain, and knee pain) and their multiple manifestations (frequency, severity, and
sensitization). This can help determine whether the associations between sleep health profiles and chronic pain
emerge across different pain conditions. Aim 1 will examine the longitudinal impact of sleep health profiles on
subsequent changes in pain for three separate pain outcomes. We hypothesize that poor sleep health profiles
are associated with: [MIDUS] new onset of any chronic pain and/or an increase in pain interference among
midlife and older adults; [MrOS] new onset of back pain and/or increases in the frequency and severity of back
pain among older men; [MOST] increases in knee pain severity and clinical sensitization among older
men/women with the risk of osteoarthritis over time. Aim 2 will examine behavioral and biological mechanisms
underlying the impact of sleep health profiles on changes in pain. We hypothesize that poor sleep health profiles
are associated with more chronic pain over time mediated by lower diversity in social activities (i.e., a less active
social life) or by a higher risk of systemic inflammation. Aim 3 will examine independent and joint effects of
behavioral and biological mechanisms underlying the impact of sleep health profiles on changes in pain. Our
multi-cohort approach also allows us to detect potential social disparities in sleep and chronic pain by aggregating
relevant racial and sex sub-groups across cohorts. This project will inform future behavioral interventions (e.g.,
sleep health intervention) to improve chronic pain in adults by identifying specific sleep characteristics, and key
behavioral and biological mechanisms linking sleep health and chronic pain.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because chronic pain imposes a substantial burden on the healthcare system and exerts an enormous impact on the quality of life of approximately 20-30% of U.S adults and their families. As poor sleep is a risk factor of chronic pain, understanding specific mechanisms of how sleep impacts chronic pain is important. The proposed research is directly relevant to the part of NIH's mission that pertains to improving the health of the nation by conducting research onsleep and pain.